Optic Stalk-Disc Development and Differentiation

Project Summary

This proposal investigates the underlying causes of human ocular diseases using mouse
models. Proposed experiments will use complex in vivo conditional (cre-­lox) mouse genetics,
mouse transgenics, histology, immunohistochemistry, confocal microscopy, in situ hybridization,
mouse embryology, single-­cell NEXTgen sequencing, bioinformatics, BAC recombineering,
qPCR, and PCR technologies to address basic, mechanistic questions about optic stalk-­disc
development and astrocyte differentiation. The Pax2 transcription factor initiates expression in
all optic vesicle cells, but becomes progressively restricted to only the forming optic disc and
stalk. Consistent with its role in other embryonic tissues, we will test a hypothesis that Pax2
shuts off neural/retinal progenitor gene programs, via global interactions with cell epigenetic
machinery. This activity initially restricts ocular cells to an astrocytic progenitor cell (APC) fate,
regulates their rate of cell division, and initiates glial gene expression profiles. In Aim 1, we will
test evolutionarily-­conserved Pax2 noncoding sequences as long-­sought optic disc-­nerve
enhancer(s) by creating a new Pax2-­Cre driver. This tool will be used to conditionally remove
Hes1 and assess the consequences to optic stalk development, APC differentiation and mature
astrocyte functionality. For Aim 2, we will take advantage of previously characterized Rax-­Cre
BAC transgenic mouse line, Pax2GFP knock-­in and new Pax2 floxed allele to follow the ocular
GFP lineages in control and Pax2 conditionally mutant cells. We will also generate and
compare the gene expression profiles of Pax2 E11 and E12 heterozygous and homozygous
mutant eyes. Here we will use single-­cell RNA sequencing and the growing wealth of publicly
available information regarding chromatin configurations, and mRNA expression levels during
the normal development of mouse ocular cells.

Public health relevance
Relevance This research advances understanding of optic cup, stalk and disc outgrowth and morphogenesis, which can be abnormal in congenital anophthalmia, microphthalmia, coloboma, pediatric glaucoma, optic neuritis, or optic nerve hypoplasia. This study creates new transgenic and mutant mouse models and will provide novel insights into formation and maintenance of the optic disc and nerve, overt goals of the NEI. This research will also provide fundamental information relevant for adult onset glaucoma. This project addresses several objectives recommended by the Retinal Diseases Panel which are to “Identify and characterize genes responsible for optic nerve disease” and “Develop transgenic and other animal models of optic nerve disease”. In a broader context, our experiments also contribute new information about the Pax2 transcription factor whose mutations also impact brain, kidney and inner ear development and homeostasis.